CLONING OF HUMAN TYPE IV COLLAGENOLYTIC GENES

Two approaches were taken for cloning the gene for type IV collagenase from a tumor cell cDNA library. A human melanoma (A2058) gamma gtll library (custom made for Dr. Liotta by Clontech Co.) was first screened with a polyclonal antibody against type IV collagenase. The collagenase was purified from culture supernatant of the A2058 cell line which was used to make the cDNA library. The second approach was to screen the melanoma library with a mammalian collagenase cDNA clone (supplied by C. Brinkerhoff). After the first screening with the antibody, 18 clones were isolated, of which four were plaque purified after 4-5 rounds of screening. All four clones produced clear plaques, which indicates an insert-bearing phage, but failed to demonstrate an insert by restriction analysis; the restriction pattern was identical to that of a wild type gamma gtll phage DNA. Likewise, negative results were obtained when the same melanoma cDNA library was screened with the mammalian collagenase clone. Six clones which were strongly positive through four rounds of screening turned out to produce no-recombinant blue plaques without an insert as judged by restriction analysis of phage DNA. Since there may be problems with the melanoma library, we will start the cloning process all over again using another tumor cell cDNA library. Presently, we are beginning to focus our attention on the role of endothelial cells in metastasis. Therefore, we are in the process of screening a human endothelial cDNA library, purchased from the Clontech Co. Using the mammalian collagenase cDNA clone under low stringent conditions, we expect to pull out mammalian collagenase and other related genes, expressed by endothelial cells.